Oklahoma Center for Microbial Pathogenesis and Immunity

Overall Component
Abstract
The Oklahoma Center for Microbial Pathogenesis and Immunity (OCMP&I) Phase 2 COBRE is a rapidly
expanding center of excellence focused on supporting and mentoring the next generation of microbiologist and
immunologists. In Phase 2 of this COBRE program, the OCMP&I supports four research project leaders and a
pilot project program. Phase 2 research projects span disciplines that include parasitology, antimicrobial
resistance, neuroimmunology, and inflammation. These projects add to the program’s growth in Phase 1, which
included fostering early career investigators studying bacteriology, innate immunity, mycology, tuberculosis,
microbiome, parasitology, bat immunity, and host-pathogen interactions. Growth in Phase 2 of this program will
expand the network of well-trained, NIH-funded investigators leading research laboratories in 11 areas of study
related to infectious diseases and immunology. The components of the OCMP&I Phase 2 COBRE include
research projects, pilot projects, research core support, and an administrative core. The research core,
Immunology and Informatics Core (IIC), will provide research project leaders with support in immune profiling
and large data set analyses as part of the next iteration of research core support established in Phase 1. The
IIC will also lead an annual course in bioinformatics at the University of Oklahoma Health Sciences Center. The
administrative core will provide administrative support, facilitate an advisory committee, organize grant writing
workshops, and oversee a pilot project program. Overall, the aims of this Phase 2 COBRE are: 1) Capitalize on
the Phase 1 accomplishments and accelerate growth of the OCMP&I COBRE. 2) Provide administrative and
research leadership to support the growth of the OCMP&I COBRE Program. 3) Select, support, and mentor
outstanding Research Project Leaders. 4) Support critical research needs through strategic core support in
program administration, immune profiling, and informatics. 5) Foster a culture of mentoring to support the
professional development of Phase 2 project leaders.

Public health relevance
Microbial infections and immunity have a dramatic impact on human health. The Oklahoma Center for Microbial Pathogenesis and Immunity Phase 2 COBRE will support and train the next generation of academic microbiologists and immunologists to advance basic research in infectious diseases and immunology. Through this effort, we will grow the network of expert scientists and advance new discoveries that can be translated into the next generation of vaccines and treatments.